Defining and Avoiding Molecular Mechanisms of Drug Resistance

Project Summary
Defining and Avoiding Molecular Mechanisms of Drug Resistance
Drug resistance is a major challenge in modern medicine. Resistance impacts the lives of millions, limiting the
effectiveness of many of our most potent drugs. This often happens under the selective pressure of therapy in
bacterial, viral, and fungal infections and in cancer due to rapid evolution. Instead of considering resistance
only after a drug fails, we need a paradigm shift to incorporate preemptive strategies into drug design to avoid
resistance. Research in my laboratory combines a variety of experimental and computational techniques to
elucidate the molecular mechanisms of drug resistance and to lay the foundation for developing strategies to
avoid resistance in drug design. The rapid evolution of viruses continues to challenge our therapies,
highlighting the significance of deciphering the intersection of evolution and resistance.
Insights from my years of research on HIV-1 protease and subsequently other viral proteases led to
fundamental concepts including that primary resistance mutations occur where inhibitors physically contact
regions of the active site beyond the substrate envelope. I hypothesized that inhibitors that stay within the
substrate envelope are less susceptible to drug resistance. Validating this hypothesis, my strategy of adding
the constraint that inhibitors must stay within the substrate envelope in structure-based drug design (SBDD)
yielded extremely potent inhibitors that are effective against resistant variants. Beyond the substrate envelope,
I have demonstrated mutations distal from the active site also significantly contribute to resistance.
My ongoing research is 1) characterizing the molecular mechanisms of these distal changes in conferring
resistance and 2) developing strategies to counter their impact. The complex and dynamic interplay between
such mutations necessitates integrated approaches. Thus, we are developing a novel strategy combining
parallel molecular dynamics (pMD) with machine learning and demonstrated the feasibility and power of this
approach in identifying key physical interactions that are indicators of resistance. We are now assessing
whether a similar approaches, optimizing various linear and non-linear machine learning algorithms, can be
used to evaluate a set of inhibitors, with various functional groups.
In the future we will leverage lessons learned, specifically the substrate envelope concept and pMD coupled
with machine learning, to a diverse set of drug targets in quickly evolving diseases. My long-term goal is to
develop broadly applicable approaches leveraging machine learning in SBDD to guide inhibitor selection, to
avoid resistance and enhance potency for diverse enzyme targets . Overall, I expect to decipher principles and
mechanisms that underlie drug resistance by developing and optimizing tools to capture the essential
dynamics of a given drug-target system toward devising broadly applicable strategies to identify robust
inhibitors that retain potency in the face of evolution.

Public health relevance
Project Narrative Drug resistance is a major problem limiting therapy options for millions of people in both infectious diseases and cancer. My research aims to understand the molecular mechanisms by which mutations in a drug target confer resistance. With this understanding, we can devise better strategies for designing drugs that would be robust and avoid resistance.